FASEB SRC: The G Protein-coupled Receptor Kinases and Arrestins Conference: Key Modulators of Signal Transduction

Project Summary
G protein-coupled receptors (GPCRs) and their downstream signaling pathways are important for the
regulation of many essential cellular processes and are targets of some of the most commonly prescribed
drugs, such as those used to treat pain, heart failure, and high blood pressure (e.g. morphine, β blockers, and
angiotensin inhibitors, respectively). GPCR kinases (GRKs) and arrestins are key regulators of GPCR
signaling. They act in tandem to promote receptor desensitization by reducing the ability of receptors to couple
with G proteins and by targeting active GPCRs for endocytosis. Although these desensitization mechanisms
are important for returning cells to their physiological resting states, GRKs and arrestins are also known to
instigate non-canonical signaling. In this regard, these proteins play prominent roles in the central nervous and
cardiovascular systems, and especially in diseases such as drug addiction and heart failure, respectively. This
proposal seeks funding for a forum that would bring together world-leading researchers who study different
aspects of GRK and arrestin biology and their roles in disease called "G Protein-Coupled Receptor Kinases
and Arrestins: Key Modulators of Signal Transduction". Two major highlights of the meeting will be two keynote
lectures who are experts in GPCR, GRK, and arrestin structure, function, and cell biology. In addition, senior
and junior scientists will be able to present their most recent and unpublished work to leaders in the field, which
should stimulate the generation of new hypotheses and methodologies and hopefully lead to the beginning of
collaborations that can be used to study and combat drug abuse and cardiovascular disease. This will be a
great opportunity for trainees to get critical feedback and make important connections, which will
benefit their career advancement.

Public health relevance
Project Narrative G protein-coupled receptors (GPCRs), which control almost all aspects of cell physiology and human behavior and are the target of a large fraction of pharmaceuticals and drugs of abuse, are regulated by two key families of proteins known as GPCR kinases (GRKs) and arrestins. Although these proteins provide a essential adaptive response in cells, they also are known to play central roles in drug addiction, metabolic disorders and heart failure. A meeting that brings together world leaders, postdoctoral fellows and graduate students who study GRKs and arrestins will accelerate the development of new hypotheses, collaborations, and methodologies that can be used to study and develop new therapeutics for drug addiction, metabolic disorders and cardiovascular disease.